NARMS Cooperative Agreement Program to Strengthen Antibiotic Resistance Surveillance in Retail Food Specimens

Project Summary:
The Minnesota Department of Agriculture (MDA) has been working with the Minnesota
Department of Health (MDH), CDC, and FDA on the Retail Food Study since its
inception in 2002. This project was designed to determine the prevalence of
antimicrobial resistance among enteric pathogens found in retail meats (including
chicken, pork, ground beef, and ground turkey). In Minnesota, MDA and MDH are
culturing all meats for Salmonella and chicken and pork/beef for Campylobacter. We are
also culturing seafood for Vibrio, Aeromonas and Enterococcus. All isolates are further
characterized by MDA or MDH and sent on to FDA for further analysis (including culture
confirmation, antimicrobial susceptibility testing, and molecular subtyping). From 2015-
2019, a total of 80 meat samples per month were tested. Starting in 2020 the sample
total dropped back to 23-40 per month and the pilot seafood study was initiated. In
Minnesota, in 2024, 12 of 84 (14.3%) chicken samples, 7 of 72 (9.7%) ground turkey
samples and 3 of 48 (6.3%) pork samples tested positive for Salmonella. Also, in
Minnesota in 2024, 19 of 84 (22.6%) chicken samples and 1 of 48 (2.1%) pork samples
tested positive for Campylobacter. From the seafood study in Minnesota, 9 of 72
(12.5%) samples tested positive for Vibrio (all shrimp samples), 36 of 72 (50%) samples
tested positive for Aeromonas (13 shrimp, 12 salmon, 11 tilapia), 51 of 72 (70.8%)
samples tested positive for Enterococcus (23 shrimp, 11 salmon, 17 tilapia), and 46 of
72 (63.9%) samples tested positive for lactose fermenters (7 shrimp, 18 salmon, 21
tilapia). MDA and MDH plan to continue our cooperative arrangement. We will
continue to collect samples from the seven-county Minneapolis-St. Paul metropolitan
area (which comprises over half of Minnesota’s population) and from rural areas of the
state as directed by FDA. This study has contributed substantial data to our
understanding of the species, serotypes, and antimicrobial resistance types of
Campylobacter and Salmonella found in various retail meats. The seafood study has
contributed data to our understanding of species and antimicrobial resistance types of
Vibrio, Aeromonas and Enterococcus in various seafoods. This data has been beneficial
in guiding our outbreak investigations where meats may have been the source of
infection in humans. We have encountered very few challenges in our experience with
this study and feel it has been a valuable tool, adding a critical component to the picture
of antimicrobial resistance in Minnesota.

Public health relevance
Project Narrative: The Minnesota Department of Agriculture (MDA) has worked with the Minnesota Department of Health (MDH), CDC, and FDA on the Retail Food Study since 2002. In Minnesota, MDA and MDH are currently culturing meat samples for Salmonella and Campylobacter, as well as culturing seafood for Vibrio, Aeromonas and Enterococcus. This study has contributed considerable data regarding species, serotypes, and antimicrobial resistance profiles of Salmonella, Campylobacter, Vibrio, Aeromonas and Enterococcus from various retail meats and seafood. This data has also contributed to foodborne disease outbreak investigations in which meats are the implicated source of human infections.